Washington University Postbaccalaureate Research Education Program

PROJECT TITLE: The Washington University Post-Baccalaureate Research Education Program (WUP)
PROJECT SUMMARY Washington University Post-Baccalaureate Research Education Program (WUP) is
designed to provide rigorous research training and enrichment activities to recent college graduates from groups
underrepresented in the biomedical sciences to better prepare them to apply, matriculate, and succeed in a PhD
program. This program is based on the understanding that an in-depth mentored research experience
supplemented with diversity and career enrichment activities will provide optimal preparation for graduate studies
in the biomedical sciences. The research experience is complemented by a multi-tiered skill-enhancement
program that integrates comprehensive scientific instruction and professional development to build self-efficacy,
scientific identity, oral and written scientific communication skills, critical thinking and analysis, and ethical
decision-making. Training in such skills is provided by a year-long WUP-specific journal club, numerous career
development workshops, an ethics course, rigor and reproducibility training, academic courses, and other skill-
building activities. Although the training program is highly structured and logically organized, it is also
personalized in that the Individual Development Plan (IDP) and the research interests of each participant are
considered when selecting Mentors for one year of laboratory-based research. Scholars will choose from an
array of mentors working in mechanobiology, biochemistry, cell biology, development biology, and regenerative
medicine. WUP mentors have outstanding records of promoting the training, education, and career advancement
of biomedical scientists and conduct rigorous, well-funded biomedical research. The WUP and its components
will be assessed at specific intervals throughout the year, through participant, mentor, and director evaluations.
The ultimate success will be measured by the matriculation of scholars into PhD programs, their completion of
PhD programs, and their long-term success in biomedical science research and research-related careers.

Public health relevance
PROJECT NARRATIVE The Washington University Postbaccalaureate Program (WUP) is a one-year, multi-pronged program designed to increase the number of underrepresented individuals matriculating and graduating from research-intensive biomedical doctoral programs. The WUP will achieve this through a rigorous mentored research experience and career and educational programs designed to enhance scientific self-efficacy, sense of belonging, identity, and communication skills of participating scholars.